Development of the MasSpec Pen Technology to Guide Surgical Decisions in the Care for Patients with Ovarian Cancer

Summary: New technologies that provide molecular-based cancer detection and tissue identification are highly
desirable to improve treatment for patients with cancer. High-grade serous ovarian cancer (HGSC) is the most
common and lethal type of ovarian carcinoma, as most patients present with metastasis and advanced disease.
Neoadjuvant chemotherapy (NACT) followed by interval debulking surgery has been increasingly used as the
main treatment for patients. Yet, most patients do not achieve complete response to NACT and still have cancer
at the time of surgery. Thus, gynecologic surgeons have the critical task of visually identifying and removing all
residual tumor lesions during surgery— a task that can be very challenging due to the drastic changes that NACT
causes to tumor tissue morphology. Inevitably, surgeons are faced with a difficult scenario: aggressively remove
suspected tumor with surrounding healthy tissue; or leave suspected treated tumor behind. Moreover, many
patients still present chemoresistant minimal residual disease (MRD) after NACT and surgery, leading to worse
outcomes. These issues escalate health care costs, place patients at risk for morbidity, and negatively affect
survival. To address these challenges, we developed the MasSpec Pen (MSPen) technology as an innovative
approach for rapid and non-destructive intraoperative tissue analysis. The MSPen employs a droplet of water to
directly extract lipids and metabolites from tissues, which are then immediately analyzed by mass spectrometry
(MS) and statistical classifiers to identify tissues in seconds. In lab studies, we showed that the MSPen metabolic
information allows identification of HGSC with 96% accuracy. In clinical studies, the MSPen was tested by
surgeons intraoperatively for in vivo tissue identification and implemented in ovarian surgeries at MD Anderson
Cancer Center (MDACC). Using MS imaging, we have further shown that metabolic data from ex vivo ovarian
cancer tissues is related to NACT response. We hypothesize that the MSPen allows identification of pre- and
post-NACT tumor tissue and MRD in vivo to guide surgical treatment, and reveals novel in vivo metabolic
patterns related to NACT response and cancer persistence. Our aims are: Aim 1. Refine the MSPen technology
for intraoperative HGSC detection in open surgeries. We will use a next-gen version of the MSPen to optimize
performance for metastatic HGSC detection in primary (n=120) and interval debulking surgeries (n=200) and
use the metabolic data from pre- and post-NACT HGSC tissues to refine statistical classifiers for metastatic
HGSC detection; Aim 2. Develop the laparoscopic-MSPen for identification of MRD after NACT and surgery in
second-look laparoscopies (n=100), in comparison to histopathology and circulating tumor DNA data from the
same patients; Aim 3. Define metabolic markers of cancer persistence and response to NACT using the in vivo
data obtained. We will also obtain ex vivo tissues from a subset of patients and leverage our expertise in MS
imaging and spatial transcriptomics to further explore metabolic patterns of MRD. Our proposal has the potential
to offer transformative benefits to surgeons in advancing the standard of care for patients with ovarian cancer.

Public health relevance
Narrative Ovarian cancer is a devastating disease and one of the leading causes of cancer deaths among women, because most women already have metastasis and advanced disease when they are first diagnosed. Women with advanced ovarian cancer are normally treated with both chemotherapy and surgery, but even with this treatment survival is very low because it is very difficult for surgeons to identify and remove all the metastatic cancer during surgery, and even after surgery many patients still have residual cancer, often requiring more treatment. To address these challenges, we propose to develop and apply an innovative mass spectrometry technology that allows ovarian cancer and normal tissues to be accurately identified in seconds and inside the patient’s body based on metabolic alterations that happen in ovarian cancer tissues, providing surgeons with the groundbreaking capability of accurately identifying cancer for removal in the operating room, thus guiding their surgical decisions and improving treatment and outcomes for patients.